ORS/ISFR 18th Biennial Meeting (Orthopaedic Research Society/International Section for Fracture Repair

PROJECT SUMMARY
Bone fractures occur in more than 25 million Americans per year, and 5-10% of those fractures fail to heal.
Fractures that show delayed or failed progression to healing account for the majority of patient disability and
costs. Thus, there is an urgent need to better understand the biology of bone healing, and to use that
knowledge to develop new diagnostics and therapeutics. We are seeking support for the 18th Biennial
conference of the International Section of Fracture Repair (ISFR), a two-day meeting in Montreal. In 2017,
the ISFR was incorporated as a section within the Orthopaedic Research Society (ORS), thereby leveraging
the outreach of the largest scientific organization in the world dedicated to orthopaedic research. The ISFR is
dedicated to the advancement and exchange of the most current scientific ideas and research findings on
fracture repair and its application to the improvement of patient care. Our mission is be the premier forum to
integrate and present cutting-edge ideas related to clinical, translational, and basic-science research of
fracture healing. With an organizational theme of “The Future of Fracture Repair”, the main sessions of the
meeting will present forward-looking research and issues, in addition to challenges facing the trauma surgeon
now: Day 1) cross-talk of bone with other tissues, the future of post-fracture rehabilitation, and next-generation
outcomes assessment in fracture healing; Day 2) nonunion, geriatric fractures and polytrauma. In a new
partnership intended to promote clinical participation and clinician-scientist interaction, the ISFR Meeting will
be held in conjunction with the 2024 Annual Meeting of the Orthopaedic Trauma Association (OTA). The first day
of the ISFR conference has been planned to provide basic and translational content of interest to researchers,
clinicians and industry professionals. The second day has been jointly organized by the ISFR and the OTA, with a
focus on the latest research on clinically relevant topics. In total, we will have an invited keynote speaker, 27
invited session speakers, and slots for 24 abstract-selected podium presentations. We anticipate an additional
30-40 abstracts selected as posters. The Program Committee is highly focused on fostering an inclusive
environment, and has strived for a diverse roster of invited speakers, in terms of gender, career stage and
URiM representation. Surgeons, biologists, engineers, and policy makers will attend the meeting and be
drawn from academia, health-care, government, and industry. A variety of activities will be focused on career
development and networking for trainees in the bone healing field.

Public health relevance
NARRATIVE The 18th Biennial Conference of the ORS/ISFR titled “The Future of Fracture Repair” will be held in October 2024. The goal of the event is to foster growth and innovation in the field of fracture repair with an emphasis on the synergy and cooperation between basic scientists and clinicians. Researchers, clinicians, industry partners, policy makers, postdoctoral fellows, and graduate students will attend the meeting to discuss the most pressing questions in the field of fracture repair and to consider bold approaches to solving those problems.